EFFICACY OF IRBESARTAN IN MILD TO MODERATE HYPERTENSION

The purpose of this study is to determine the dose of irbesartan which will safely and most effectively lower blood pressure in patients with mild-to moderate hypertension.